Cardiovascular disease, preeclampsia, and microchimerism

PROJECT SUMMARY
Cardiovascular disease (CVD) is the leading global cause of mortality in women, with significant sexual
dimorphism in disease phenotypes. Reproductive events may play a role as women with preeclampsia (PE)
carry an approximately 2-8 fold increased risk for CVD later in life. Although shared risk factors certainly play a
role, some epidemiologic data suggests that pregnancy itself may confer some risk. One durable pregnancy-
specific physiology is fetal microchimerism (FMc), a small number of fetal cells transferred to the mother during
pregnancy, which are detectable for decades after delivery. Obstetric factors may influence this transfer, and
cellular FMc acquisition is known to be higher in women with PE pregnancies at the time of diagnosis.
Importantly, persistence of FMc cells is implicated in later-life autoimmune disease possibly due to a graft
versus host response resulting in inflammatory change. A similar mechanism may be at play in CVD
development, as evidenced by increased atherosclerosis and vascular dysfunction noted in women with a
history of PE pregnancies. One limitation of detailed assessment of FMc in later-life adult disease is the
methodology of detecting FMc itself. Current techniques rely on maternal and offspring genotyping to detect
non-shared polymorphisms followed by use of customized, cell-line based quantitative PCR assays. This multi-
step process is burdensome and often not feasible in post-reproductive years or using currently existing
cohorts of relevant diseases, such as CVD, due to lack of family samples. Current next-generation sequencing
(NGS) technologies hold promise in overcoming these limitations. The overarching goal in this proposal is
to investigate a novel pathway between CVD and PE by testing the hypothesis that women with CVD
and a history of PE pregnancy will more frequently harbor persistent FMc and at greater levels
compared to women with uncomplicated pregnancies. Parallel to this, we will expand the applicability
of an advanced NGS approach for FMc detection and quantification to catalyze important studies for
understanding the implications of this unique phenomenon in CVD and other diseases. Through these
combined efforts, I will gain expertise in CVD research and molecular techniques to better understand
reproductive origins of disease, helping to establish my career as a translational physician scientist.

Public health relevance
PROJECT NARRATIVE The proposed studies seek to understand whether a small number of fetal cells transferred to the mother during pregnancy (fetal microchimerism) is associated with later-life cardiovascular disease (CVD) in women with a history of preeclampsia. In parallel, we will expand the usability of an advanced next-generation sequencing approach for improved microchimerism evaluation. This work will modernize the techniques for microchimerism studies while investigating a possible contributor to CVD in a unique cohort of women with the potential to identify novel diagnostics and therapeutic interventions to limit the burden of disease.